Research Education Core

ABSTRACT
The primary goal of the Yale ADRC Research Education Component (REC) is to foster the careers of junior
investigators from a variety of scientific backgrounds relevant to the fields of Alzheimer’s disease and related
dementias. The REC Core will continue building on Yale and the ADRC's successful track record in supporting
the careers of junior investigators. We will use all the ADRC resources to facilitate and promote rigorous,
innovative, and high-impact biological, translational, and clinical research to ultimately position REC Scholars
as future leaders in dementia research. To achieve these goals, the REC will coordinate closely with all other
ADRC Resource Cores, including the Community Outreach Core. Additionally, to encourage investigators to
explore the mechanistic heterogeneity of dementia, including systemic and aging factors, we will continue to
link our REC educational and networking activities with those of the Yale Older Americans Independence
Pepper Center. The REC will continue to offer personalized mentorship programs and comprehensive,
interdisciplinary courses addressing key research, leadership, teaching, and grant writing skills. The REC will
also provide varying levels of financial support, along with relevant technical training and priority access to all
ADRC research cores. ADRC Scholar awards will support established projects, while REC Pilot awards will
support preliminary research to enable future applications for ADRC Scholar funding. In addition, we will seek
to expand our REC Affiliate network with a broad range of investigators from all fields with potential relevance
to dementias, facilitating their access to ADRC resources, didactic, career development, and academic
activities. Overall, the REC will continue to serve as a hub for all educational, didactic, and career development
activities aimed at promoting the development of future leaders who will bridge clinical and basic sciences to
improve clinical outcomes and the quality of life of individuals with dementing disorders.